Profiling the human gut microbiome for potential analgesic bacterial therapies

The human gut microbiome is an essential component of host physiology: it modulates immune activity, influences the balance of neurotransmitters both peripherally and centrally, and produces a vast and variable array of small-molecule metabolites which enter circulation to impact distal body sites. It is highly heritable, implying a symbiosis that has developed over evolutionary timescales, but is also susceptible to the influence of diet and other factors such as antibiotic use. Notably, disruptions in microbiome composition are associated with a number of disorders characterized by chronic pain and inflammation, such as rheumatoid arthritis and fibromyalgia. Given the microbiome’s immunomodulatory and metabolic capacities, and its role as a pseudo- endogenous component of human biology, human gut-derived bacteria are a promising potential source of novel, safe, and non-addictive therapeutics for pain management. However, the mechanisms underlying the “gut?pain axis” are still being elucidated, and key functional drivers of the observed connections have yet to be identified. As such, to advance the development of microbiome-derived biotherapeutics for pain management, the goals of this project are: to identify human-gut-native bacteria capable of engaging established pain targets in vitro, to validate their activity and analgesic/anti-inflammatory potential in vivo, and to develop a computational tool to predict microbial-genetic drivers of response, which can guide future mechanism validation and therapeutic development. Because the vast majority of human gut bacteria are strictly anaerobic, they cannot be cultivated using typical laboratory equipment and techniques. This has historically presented a roadblock in mechanistic explorations of the gut microbiome’s therapeutic potential, resulting in a focus on “culture-independent” methods such as metagenomics—approaches that produce a wealth of correlative data, but little by way of causal validation. Holobiome is uniquely suited to meet this complex challenge, having overcome the difficulties inherent in anaerobic cultivation to build an in-house strain library of nearly ten thousand bacterial isolates from a variety of donors which contains representatives of nearly every major human gut-bacterial taxon cultured to date. This resource, along with an assembled team bringing extensive experience in microbiology, mammalian cell culture and assay development, and computational genomics, will allow a diverse library of human gut bacteria to be individually screened for their capacity to modulate cytokine response, cyclooxygenase expression, TRP channel activity, and other targets with high therapeutic potential for pain. This approach is expected to provide concrete insights on the mechanisms by which the gut microbiome influences nociception and the inflammatory response, with implications for the development of novel non-opioid analgesics. Findings of this research may also have translational potential for the treatment of autoimmune disorders, cancer, and neurodegenerative diseases such as Alzheimer’s Disease, which has both autoimmune components and demonstrated links to the microbiome.

Public health relevance
While a rapidly growing body of research ties perturbations in the human gut microbiome to countless aspects of health and disease, most of this work is correlative in nature and provides relatively little information regarding the direction of causality and the mechanisms involved. This project, which aims to identify human gut-native bacteria capable of modulating nociception and inflammation, will generate valuable insight on the roles of specific gut taxa and bacterial genes in regulating pain sensitivity. The outcome of this project will represent a major step toward the development of novel non-opioid analgesics with a strong safety profile, which may also help stem the ongoing opioid crisis.